The effect of noise induced hearing loss on Alzheimer's disease development and progression

Summary
Alzheimer's disease (AD) is a common neurodegenerative disease characterized by a progressive loss of
memory and cognitive decline. Over the last decade, the prevalence of AD and AD-related dementia (ADRD)
has been rapidly growing. It is predicted that there will be 150 million AD patients by the year 2050, tripling the
number in 2018. This will cause severe economic and social burdens. It has been estimated that speeding up
the onset of dementia by even one year would increase the worldwide prevalence of dementia by 10%.
However, currently, little is known about causes or mechanisms for this rapid increase in AD population. Many
factors, particularly environmental factors, have been proposed as potential contributors to this rapid increase.
Noise is a common high-risk environmental factor for human health and also a common deafness factor. Noise
can induce hearing loss; hearing loss can induce and accelerate cognitive decline. In particular, recent studies
demonstrate that noise can induce hidden hearing loss (HHL), which is caused by noise-induced inner hair cell
synapse degeneration leading to difficulty of speech understanding in communication and therefore eventually
social isolation. Currently, our world is becoming more and more noisy due to traffic, TV, and wide use of
personal audio and video devices. We hypothesize that noise is a high-risk factor for AD development and may
play an important role in AD population growing. To test this novel hypothesis, we will investigate whether
noise can accelerate AD development and progression in AD mice (Aim 1). We will also investigate whether
AD can impair the cochlear efferent system, which plays a critical role in the protection of hearing from noise,
to increase susceptibility to noise and in turn to accelerate AD development and progression (Aim 2). In Aim 3,
we will further investigate whether deficiency of ATP-purinergic function can accelerate AD development and
progression, since our previous study found that deficiency of ATP-purinergic signaling function could induce
hearing loss and increase susceptibility to noise. ATP-purinergic signaling also plays an important role in
neuroinflammation, which is a consequence of noise exposure and plays a critical role in AD development and
progression. Therefore, ATP-purinergic receptors have been considered an excellent potential target as well
for AD prevention and treatment after anti-amyloid clinical trials have failed. These proposed studies will help
to identify high-risk factors or contributors to the rapidly growth of the AD population and elucidate underlying
mechanisms, thereby laying the foundation for development of new preventive and therapeutic interventions
for AD and ADRD. Particularly, recent studies reported that visual and auditory stimulations with gamma
oscillation cycles could reduce Aȕ expression in the brain and improve memory in AD mice, further indicating
that the auditory system has a critical role in AD development and progression.

Public health relevance
Project Narrative: Environmental factors may play a critical role in the recently rapidly growing of the prevalence of Alzheimer's disease and dementia, which causes a heavy economic and social burden. Noise is a common high-risk environmental factor for human health and is also a common deafness factor. In this project, given current world inundated with noise pollution now, we will investigate whether noise and noise-induced hidden hearing loss can accelerate AD development and progression to contribute to this increase, which can be expected to have great impact on prevention and therapeutic interventions of AD and dementia.